Quantifying and Personalizing the Clinical Benefit of Metastasis-Directed Therapy in Men with De Novo Oligometastatic Prostate Cancer

Project Summary/Abstract
The long-term goal of this project is to determine the clinical impact of metastasis-directed radiotherapy (MDT)
in men with de novo oligometastatic prostate cancer (PCa), and identify which men may be cured and benefit
most from MDT. We aim to achieve this goal through the conduct of a phase 3 randomized controlled trial with
prospective imaging and biospecimen (e.g. tissue and blood) collection. This trial is novel in that it is a
randomized North American sub-study (n=200) of the next arm (Arm M) of the international landmark multi-
arm, multi-stage, STAMPEDE trial. The ability to conduct this trial with comprehensive biospecimen collection
and imaging analysis will be achieved through our unique research team across extramural and intramural
centers, comprised of experts in prognostic and predictive biomarker signature identification, bioinformatics,
biostatistics, genomics, imaging, and clinical trial execution. We will leverage the opportunity for North America
to participate in the STAMPEDE trial to not simply identify the true impact of MDT in the first ever large phase 3
trial testing MDT in PCa, but use this one of a kind clinical trial working with the NCI to develop the first
predictive biomarkers of benefit of MDT using radiomics of conventional and molecular PET imaging, as well
as sequencing of primary, metastatic, and liquid biopsies. This goal will be carried out through three specific
aims. Aim 1 will focus on the conduct of the phase 3 randomized North American sub-study to determine if the
addition of MDT to standard systemic therapy and treatment of the primary improves failure-free survival. Five
centers will participate, including the NIH Clinical Center. These patients will all be included in the international
STAMPEDE trial with the primary endpoint of overall survival. Aim 2 will leverage the baseline CT and bone
scans collected on all patients, as well as a subset that will be sent to the NCI to have pre-treatment 18F-
DCFPyL PET/CT scans performed (n=50). Radiomic analyses and image feature extraction will be performed,
and this information will be used to identify which men benefit most from MDT. We hypothesize that a subset
of men will benefit most from MDT and be identifiable through an imaging biomarker. Aim 3 will utilize the
baseline prostate biopsy, metastatic biopsies, radical prostatectomy specimens, and liquid biopsies (circulating
tumor cells and cell-free DNA), to annotate the molecular landscape of oligometastatic PCa. This data will
then be used to develop a predictive biomarker to identify which men benefit most from MDT. International
patient samples will be banked for later validation. We hypothesize that a discrete molecular profile will
characterize which men are most likely to be cured from MDT. The impact of this work is extremely large, as it
has the potential to cure a currently incurable subset of men with metastatic PCa. Successful completion of
these aims would result in predictive biomarkers that could directly impact the clinical management of men with
oligometastatic PCa, and transform current treatment paradigms.

Public health relevance
Project Narrative The current standard of care treatment for men with newly diagnosed oligometastatic prostate cancer (PCa) is non-curative and this disease remains near uniformly fatal. The use of metastasis-directed therapy (MDT) in combination with systemic therapy and treatment of the primary has the potential to cure a subset of these men, but currently there is no biomarker to identify which men may benefit from this approach. The lack of imaging and molecular biomarkers to address this problem is a critical unmet need, and by leveraging the first phase 3 randomized trial assessing the benefit of MDT as part of the international STAMPEDE trial, we plan to quantify the benefit of MDT, and produce predictive imaging and molecular biomarkers to personalize treatment decisions and maximize each individual’s treatment response to MDT.